Focused Ultrasound and CAR T Cells for Pediatric Brain Malignancies

Project Abstract
Pediatric brain tumors represent a notoriously difficult, yet delicate, class of cancers with an urgent need for
safer, more effective treatment options. Medulloblastoma (MB), the most common malignant brain cancer in
children, is classified by four major subtypes; its molecular heterogeneity underscores the largely ineffective
nature of current treatment options, which often harbor debilitating side effects and risk of chronic cognitive
impairments. As such, there is a critical need for safer, selectively targeted approaches that can improve
treatment efficacy while minimizing adverse effects. Adoptive cellular therapies have seen profound success as
a treatment strategy in specific blood cancers, but their success in solid tumors – in particular, those resident in
the brain – has been limited. Unique challenges for cellular therapy in MBs is multifactorial and includes: (1) the
suppressive tumor microenvironment consisting of immunosuppressive signaling and dense stromal barriers; (2)
limited local cellular infiltration and persistence; (3) heterogeneous antigen expression and antigen escape; and
(4) high systemic toxicities. Direct intracranial administration of cellular therapies has displayed marginal success
in overcoming these limitations but remains an unfavorable option due to its highly invasive nature. This
underscores a critical and urgent need for novel, targeted approaches that can improve treatment efficacy for
MB while minimizing adverse effects.
Magnetic resonance imaging-guided focused ultrasound (MRgFUS), a burgeoning transcranial intervention
strategy, represents a unique and promising approach for potentiating adoptive cellular therapy delivery to MB
in a non-invasive, non-ionizing manner. Our group and others have shown that MRgFUS, in combination with
microbubbles, drives mechanical effects that can be tuned to yield blood brain/tumor barrier opening for
augmented therapeutic delivery, as well as controlled modulation of sterile inflammatory signatures, in primary
or secondary brain tumors. We posit that the sono-immumomodulatory bioeffects of FUS, alongside its capacity
to promote targeted delivery of cell products and/or allied immune-adjuvants, will enable more robust, less toxic
MB therapy. In an effort to tackle on of the most aggressive subtypes of MB, characterized by accelerated growth
and frequent metastasis, this proposal takes specific aim at group 3 (G3) MB, leveraging unique mouse models
of G3 MB that faithfully recapitulate human disease and bringing them together with MRgFUS for the first time.
The proposed grant will interrogate the capacity of spatially tunable MRgFUS interventions to potentiate adoptive
cellular immunotherapy (B7-H3-targeted CAR T cells) in immunocompetent preclinical models of G3 MB -
leveraging cutting-edge tools such as serial immunoPET imaging, multispectral flow cytometry, and digital spatial
profiling to inform this process. Given the clinical relevance of the proposed models and interventions, as well
as the translational expertise and history across investigating sites, we expect that findings from this proposal
would be ripe for rapid clinical translation and extension to other pediatric brain tumor settings.

Public health relevance
Project Narrative Medulloblastoma (MB) is the most common pediatric brain tumor and treatment of patients with high-risk subtypes remains notoriously difficult due to disease complexity, its challenging niche within the immunologically- and pharmacologically-privileged central nervous system, and the significant risk of long-term developmental deficits due to treatment toxicities. To this end, promising novel treatment options such as cellular immunotherapy have not yet found broad success in this disease setting. Our proposal leverages image-guided focused ultrasound intervention as a novel non-invasive, non-ionizing strategy for augmenting targeted cellular delivery and persistence in high-risk MB.